Characterizing Trauma and its Impact in the Yurok Tribe

ABSTRACT
Approximately 16-24% of American Indian/Alaska Native (AI/AN) people exhibit post-traumatic stress disorder
(PTSD). Left unresolved, trauma is believed to contribute to marked health disparities, including higher rates of
community and interpersonal violence, suicide, and child and substance abuse in Native communities. The
Yurok tribe, residing in Humboldt and Del Norte County, California, has endured genocide, enslavement,
dislocation, and various forms of physical, mental, and social oppression, which have been shown to manifest
in high rates of historical and interpersonal trauma and contribute to marked health disparities. Importantly,
rates of suicide and drug overdose deaths are higher in Humboldt County than national rates. Further
compounding these disparities is the rural location, absence of trauma-focused treatment, and shortage of
mental healthcare providers. Narrative Exposure Therapy (NET) is a community-driven, evidence-based form
of trauma therapy that can be performed with peer and lay counselors. Our program of research seeks to
adapt and implement NET with Yurok lay counselors. However, prior to adaptation and implementation,
community data on trauma and its effect is necessary. Aim 1: Characterize trauma (type, severity, and
frequency of symptoms) and assess the relationship between trauma, harmful behaviors, and cultural
engagement. Aim 2: Conduct in-person qualitative semi-structured interviews with Yurok tribal members to
contextualize findings from Aim 1 and obtain an in-depth understanding of the relationship between trauma,
cultural engagement, and harmful behaviors. The proposed study aligns with the National Institute of Nursing
Research’s (NINR) interest in health disparities and the research lens, Population and Community Health. The
results will be the first to document and characterize trauma and its effect in this community as well as identify
cultural frameworks that promote resilience and healing. The results will inform the next steps of our program
of research by providing essential information to adapt and implement a NET intervention within the Yurok
tribe. Successful implementation of NET will address barriers to mental healthcare access for this community
and will be the first step towards restorative justice for the Yurok.

Public health relevance
PROJECT NARRATIVE American Indian/Alaska Native (AI/AN) communities suffer from high rates of trauma, post-traumatic stress, and poor mental health outcomes. Our program of research aims to develop a community-driven, evidence- based intervention, Narrative Exposure Therapy, with Yurok peer counselors in the Yurok tribe, the largest surviving federally recognized tribe in the U.S. Prior to venturing into implementation work, this mixed methods study seeks to characterize trauma and understand its effect in this community as a crucial step to understand how to tailor the intervention to the community’s needs as well as their strengths.